Animal Model Shared Resource

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
ANIMAL MODEL SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
The objective of the Animal Model Shared Resource (AMSR) is to provide a comprehensive a service for the
generation, housing, and analysis of mouse models of human cancer. The AMSR provides services for the
modification of the mouse genome through CRISPR/Cas9 gene targeting technology as well as conventional
gene targeting in embryonic stem (ES) cells. The AMSR generates conventional knockout mouse lines, knock-
in mouse lines and mouse lines with conditional alleles for the temporal and spatial ablation of genes. The AMSR
also provides services for the generation of transgenic mouse lines either by conventional random transgene
integration, or by targeted insertion of transgenes into safe harbor genomic loci to ensure stable gene expression.
An AAALAC-accredited AMSR animal facility provides specific pathogen-free (SPF) rodent housing and a broad
spectrum of animal husbandry services, as well as the services of a board-certified veterinary pathologist.
Comprehensive mouse reproductive services for embryo and sperm cryopreservation and re-derivation of
transgenic and gene-targeted mouse lines as well as IVF services are offered. The AMSR established a Gene
Modification Service to provide a complete service for the rapid and cost-efficient generation of genetically
modified mouse lines to MECC investigators. Furthermore, the AMSR provides a robust array of xenograft
methodologies for cell implantation and propagation of tumor grafts by serial transplantations, and supports pre-
clinical studies on novel anticancer agents in murine tumors as well as in human patient-derived tumor xenografts
(PDX). Finally, the AMSR provides in vivo IVIS imaging of animals bearing tumors that express bioluminescent
or fluorescent proteins, allowing non-invasive quantitation of tumor growth in mice. The AMSR has three Specific
Aims to accomplish these goals: 1) To provide comprehensive services required for the generation of genetically
modified mouse models of human cancer and the generation of xenotransplantation mouse models for studying
hematologic malignancies and patient-derived solid tumor xenografts; 2) To provide services for husbandry and
preservation of genetically modified mouse lines including sperm and embryo freezing for cryopreservation, re-
derivation of transgenic and gene-targeted mouse lines and in vitro fertilization (IVF) services; and 3) To provide
innovative methods and technologies to support MECC research including novel CRISPR technologies such as
base edit technology, CRISPR interference (CRISPRi), CRISPR activation (CRISPRa) and CRISPR RNA
technology for knockdown of gene expression as well as novel imaging technologies to increase the range of
detectable fluorescent labels in tumor cells.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward ANIMAL MODEL SHARED RESOURCE - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page